Extrastriate Mechanisms of Visuospatial Perception During Eye Movements

PROJECT SUMMARY
We move our eyes thousands of times each day, adding up to over an hour of our waking perception. These
eye movements create considerable difficulties for the brain’s visual processing system, which must suppress
the induced motion of the visual scene caused by the eye movement and provide a stable visual perception
despite these discontinuities. How the visual system deals with the potentially disruptive consequences of our
frequent eye movements is a question with direct relevance for our everyday visual perception, and especially
to disorders in which eye movements are abnormal or the integration of information is impaired, such as
schizophrenia, attention deficit hyperactivity disorder, and autism spectrum disorders; the integration of
information across eye movements may be particularly important in reading, and potentially impaired in mental
disorders such as dyslexia. Aim 1 of this proposal develops a novel statistical approach capable of producing
an encoding model which captures the fast changes in neural sensitivity around the time of eye movements,
and linking this activity to a perceptual readout. This approach reveals a novel neurophysiological
phenomenon—persistent activity in response to stimuli appearing near the time of the saccade—which
contributes to integrating the visual scene across saccades. In Aim 2, we apply the same modelling framework
to the phenomenon of perceived changes in the location of visual stimuli around the time of saccades, and
measure this phenomenon behaviorally in nonhuman primates. The impact of Frontal Eye Field (FEF) activity
on the modulation of extrastriate neuronal responses during eye movements is causally tested using
pharmacological manipulation in Aim 3. The combination of psychophysical, electrophysiological,
computational, and causal manipulation techniques used in this proposal promises an unprecedented level of
insight into how our brain actively reconstructs the visual world three times a second to provide us with a stable
sense of the visual world during eye movements.

Public health relevance
PROJECT NARRATIVE Humans move their eyes several times a second, and each of these eye movements is accompanied by changes in our visual perception, including distortions of location and duration. The proposed series of electrophysiological, psychophysical, and statistical modeling experiments will identify neuronal changes and brain areas involved in changes in perception around the time of saccades, with direct implications both for understanding normal vision and for disorders involving impaired integration of information across eye movements, such as schizophrenia, attention deficit hyperactivity disorder, dyslexia, and autism spectrum disorders.